Operant conditioning of the wrist extensor motor evoked potential to target corticospinal plasticity and upper limb motor recovery after cervical spinal cord injury

PROJECT SUMMARY/ABSTRACT
Corticospinal function is essential in generating and controlling voluntary movements. Cervical spinal cord injury
(SCI) disrupts corticospinal connections, therefore, often results in weak voluntary activation of muscles and
impaired motor control in the upper limb (UL). An intervention that improves corticospinal function could enhance
motor function recovery; however, such interventions are not currently readily available to people with incomplete
SCI. Operant up-conditioning of a motor evoked potential [MEP] to transcranial magnetic stimulation (non-
invasive brain stimulation) that can increase corticospinal excitability for the targeted muscle may be able to fill
this gap. The overarching hypothesis is that targeting beneficial plasticity to the corticospinal pathway can
change the brain and spinal cord and improve upper limb motor function in people with chronic cervical SCI. As
initial steps towards testing this, the proposed project aims to apply MEP operant up-conditioning in the wrist
extensor of the affected UL, improve corticospinal activation of the wrist extensor, and thereby improve motor
functions in which the wrist is involved in individuals with cervical SCI. Recent studies suggest that MEP up-
conditioning is feasible and can increase MEP size that reflects corticospinal excitability. Building on those
studies, this project will examine the effects of wrist extensor MEP operant up-conditioning in people with chronic
cervical SCI. Individuals with weak wrist extension due to incomplete cervical SCI will undergo a standard MEP
up-conditioning protocol (6 baseline and 24 up-conditioning sessions over 10 weeks). Before and after the
intervention period, neurophysiological measurements, clinical and functional assessments, neuroimaging of the
spinal cord and brain will be performed. The results will facilitate development and clinical translation of MEP
operant conditioning as a novel non-invasive therapy that may complement other therapies and further enhance
motor function recovery in people with SCI or other disorders, which aligns with the mission of NICHD to optimize
the abilities of individuals with neurological disorders.
The proposed project serves as a career development and research training opportunity for the applicant. Over
the course of proposed two years, the applicant will acquire unique research skills that are essential in the
applicant’s future SCI research as an independent principal investigator; those include, but not limited to, MEP
operant conditioning (which is available only at the Medical University of South Carolina [MUSC] EPOC lab),
neurophysiological assessment, spinal imaging, and advanced brain imaging. The applicant will also receive
career development education/training, such as clinical trial design/implementation, grant writing, and DEI and
leadership skills. In combination with frequent virtual meetings with non-MUSC mentorship team members, most
of in-person training will occur at MUSC. Neuroimaging, neuromodulation, and rehabilitation research programs
have been rapidly growing at MUSC, providing an ideal training environment for the applicant to start developing
own independent career as a successful academic researcher in neurorehabilitation.

Public health relevance
PROJECT NARRATIVE Developing new neurorehabilitation approaches is critically important for maximizing function recovery and re- establishing an active, productive, fulfilling life in people after spinal cord injury (SCI). Through this project, we seek to examine the physiological and functional effects of a new intervention with non-invasive brain stimulation to strengthen the activation and control of upper limb muscles, which were weakened by cervical SCI. Successful completion of this project will accelerate clinical translation of operant conditioning training with non-invasive brain stimulation that may complement other therapies and further enhance recovery in people with SCI or other disorders.